Core B: Proteomics and Biophysics

PROJECT SUMMARY
The Proteomics & Biophysics Core (Core B) will provide high-quality reagents and services to support all
projects in the program. The reagents include recombinant tau and TREM2 proteins as well as synthetic Aβ
peptides. The Core will also perform comprehensive biophysical measurements on proteins to provide
structural information. Additionally, mass spectrometry-based methods, such as quantitative proteomics,
hydroxyl radical protein footprinting and mass spectrometry imaging, will be utilized to analyze the chemical
composition and spatial distribution of Aβ and tau aggregates in brain sections, as well as conformational
“footprints” of both Aβ and tau prions.
In addition to using standard “best-practice” technologies, we will develop and implement several emerging
techniques that have recently shown great promise by us and others in the field. For example, hydroxyl radical
protein footprinting has been used to study soluble proteins and, more recently, applied to amyloids. This
method will be used to obtain conformational differences among prion strains. Moreover, mass spec imaging
and traditional immunohistochemistry complement each other. When combined, these two methods will
provide more detailed information about the chemical composition and much higher spatial resolutions.
Importantly, Core B will be operated by highly experienced biochemists and biophysical chemists to ensure
highest quality reagents and services.